Unraveling sources of hepatitis B surface antigen before and after nucleos(t)ide analogue treatment in People with HIV

Chronic hepatitis B (CHB) affects over 250 million people worldwide, with ~1 million annual deaths due to liver
disease and hepatocellular carcinoma. Up to 28% of persons living with HIV (PLWH) also have CHB. Since
HIV increases liver disease progression from CHB and because liver disease is a leading cause of mortality in
PLWH taking antiretroviral therapy, developing a HBV cure is imperative. Current nucleos(t)ide (NUC) therapy
can stop HBV replication but cannot cure CHB because it does not eradicate the stable covalently closed
circular DNA (cccDNA), the template for HBV replication, from the hepatocyte. The US FDA defines HBV cure
has elimination of hepatitis B surface antigen (HBsAg) from blood. The simplicity of this definition is belied by
the complexity of the source of HBsAg, which derives from either the cccDNA or HBV DNA that is integrated
into the host genome (iDNA). Distinguishing the contribution of these two sources to HBsAg is important to
target developing a cure. Further, our data using the novel techniques of single cell laser capture
microdissection (scLCM) and droplet digital PCR (ddPCR) demonstrate that NUCs unexpectedly decrease
transcription of pgRNA from cccDNA but whether transcription of S is also reduced is unknown. To address
these knowledge gaps, we propose to determine the contribution of cccDNA and iDNA to HBsAg at the single
hepatocyte level before and during NUC in 5 HIV-HBV co-infected individuals with paired archived liver tissue.
This proposal will use archived paired liver tissue from 5 HIV-HBV co-infected individuals of whom 2 were not
and 3 were on NUCs at biopsy 1. At biopsy 2, obtained ~3 years later, all 5 individuals were on NUCs. Aim 1
will use RNA seq on bulk liver tissue from biopsy 1 to construct surface (S) transcript maps, which will allow us
to determine the proportion of S transcripts that originate from cccDNA versus iDNA. The latter are
distinguished because iDNA will terminate in the human genome. The maps will then be used to find major
breakpoints in S that occur with integration allowing development of a multiplex ddPCR to study single
hepatocytes. This multiplex ddPCR will be applied to 100-200 single hepatocytes dissected with scLCM to
uniquely quantify the S transcripts from cccDNA versus iDNA in each hepatocyte from biopsy 1. Aim 2 will
then utilize hepatocytes from biopsy 2 to understand how NUCs affect these proportions. Data from Aims 1
and 2 will be correlated with plasma quantitative HBsAg. We will also determine if NUCs affect global cccDNA
transcription or only for pgRNA by combining these data with our prior data from the same hepatocytes.
Our research will broadly impact the field by using novel techniques to determine the proportions of HBsAg
from cccDNA or iDNA, which will inform the rational design of therapies for HBV cure. In addition, this proposal
will determine whether NUCs can silence cccDNA globally or are only specific for pgRNA.

Public health relevance
There is no cure for chronic hepatitis B, which is the leading cause of liver disease and liver cancer worldwide and occurs in up to 28% of persons living with HIV. Hepatitis B cure is defined as clearance of circulating hepatitis B surface antigen, which derives from two sources in the liver; however, the contribution from each source is unknown and is important to determine to target development of cure therapies. This proposal uses novel techniques to quantify, in hundreds of individual hepatocytes from paired liver biopsies in 5 HIV-HBV co- infected individuals, the contribution from each of these sources to the circulating antigen and how nucleoside analogues affect these proportions.